CHEMICAL RESEARCH IN THE DEVELOPMENT OF NEW ANTICANCER DRUGS

The objective of this work is the discovery of new drugs which are clinically useful against cancer. The following topics are of current interest: 1) synthesis and evaluation of differentiating agents, 2) plasma stability of spiromustine analogs, 3) ara-AC intracerebral antitumor activity, 4) antitumor, antiviral and cytidine deaminase inhibition of zebularine and 5) potentiation of AZQ CNS antitumor activity.